ATP-responsive Nanoparticles for Reversal of Immune Evasion in Breast Cancer

Summary
Antibody-drug conjugates (ADCs) have driven a revolution in the treatment of breast cancer; however, the
long-term benefits on patients are still heterogeneous. ADCs induce immunogenic cell death of cancer cells,
leading to anticancer immunity, and this plays a key role in antitumor response of ADCs. Therapy-induced
anticancer immunity is often limited by immunosuppressive mechanisms posed by the tumor microenvironment
(TME). Treatment of breast cancer cells with trastuzumab-emtansine (T-DM1), an ADC, causes extracellular
ATP release, which initiates the recruitment of innate immune cells and in the priming of anti‐tumor immunity.
However, extracellular ATP in the TME is quickly degraded into immunosuppressive adenosine via the concerted
enzymatic activities of CD39 and CD73, dampening anticancer immunity. We hypothesize that ATP-responsive
delivery of CD39/CD73 inhibitors with boronic acid (BA)-containing nanoparticles enables complementation of
ADCs’ actions and the NP delivery, leading to synergistic anticancer actions at two levels. Firstly, cancer-
targeting ADCs generate ATP to trigger the release of CD39/CD73 inhibitors from the NPs only in tumor sites,
preventing off-target effects in normal tissues. Thereafter, the released enzyme inhibitors prevent conversion of
ATP to Ado, enhancing and prolonging the immunogenic actions by ADCs, leading to durable tumor response.
We have prepared BA-containing nanoparticles for ATP-responsive drug delivery. CD39 inhibitor ARL67156
(ARL), a nucleotide analogue, is loaded to the nanoparticles through the interaction with BA. The nucleotide drug
can be released from the nanoparticles through replacement with ATP and other nucleotides. In preliminary
studies, treatment of breast cancer cells with T-DM1 followed by NP-ARL increased extracellular ATP
concentration and reduced the presence of adenosine. Combination therapy with T-DM1 and NP-ARL in
EO711/HER2-bearing mice remodeled the TME into an immunostimulatory landscape. This change of immune
landscape led to excellent immune-medicated tumor response in this syngeneic mouse model of breast cancer.
In this proposal, we will explore the mechanisms for immune activation produced by ATP-responsive drug
delivery, and will then enhance anticancer activity of our approach for providing an effective and safe therapy of
HER2-low breast cancer. This project can be directly translated into a novel cancer immunotherapy treating BC
that is aggressive and highly immune heterogeneous. Studies of this project will test the feasibility of using BA-
based nanoparticles as a new delivery system for drug targeting, and thus will open a new research horizon for
delivery of nucleotide/nucleoside drugs that can treat various diseases.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will lead to a clinical solution treating metastatic breast cancer, a disease that conventional approaches have failed to treat. Considering wide presence and great significance of purinergic signaling in various immune-related diseases, this project is expected to have broad translational importance in disease-specific immunotherapy.